CORE -- BIOCHEMISTRY/MOLECULAR GENETICS

This core will be responsible for the selection and enrollment of all Ss in the 3 projects of the PPG. All of the projects will collect data on the same group of subjects.. Thus, the operation of this core is critical to the conduct of the Program Project. A second task of the Core will be the supervision of the administration of psychosocial measures to all participants. These measures will be used by all projects. In order to facilitate the coordination of the experimental protocols, the psychosocial measures will be administered by Ms. Efland has part of the project 1 and 2 study protocols.